Role of glycosylation in environmental and genetic schizophrenia risk

DESCRIPTION (provided by applicant): Manganese (Mn) is an essential metal required for normal
neural development and function; however, at elevated levels, it is neurotoxic. Adults and children
exposed to Mn through environmental or occupational sources exhibit incurable motor and cognitive
deficits. Mn overexposure is also associated with a-synuclein aggregation and increased risk for
developing Parkinson’s Disease. Mn presents an environmental health concern, but the mechanisms of
brain Mn homeostasis and the effects of Mn on brain function remain are not fully understood. Upon
overexposure, Mn builds up in the basal ganglia; however, the specific neuronal targets of Mn are
unclear. A major question in the field is whether Mn primarily effects catecholaminergic, particularly
dopaminergic, or GABAergic neurons in the basal ganglia. The proposed study aims to address this
question by selectively increasing Mn in catecholaminergic and GABAergic neurons which was not
previously possible. Homozygous mutations in the Mn efflux transporter, SLC30A10, resulted in
increased brain Mn and Mn-induced parkinsonism. The current proposal leverages the discovery of
SLC30A10 to understand the mechanisms of brain Mn homeostasis and the effects of increased Mn in
all or some neurons. Using full-body, pan/neuronal/glial, liver-, and endoderm-specific Slc30a10
knockout mice, we discovered that under basal conditions, brain Mn levels are primarily regulated by
activity of SLC30A10 in the digestive system, while its activity in the brain protected against
neurotoxicity during Mn overexposure. This work established the predominance of SLC30A10 in
regulating brain Mn levels and presented a novel method for studying Mn neurotoxicity. Subsequent
work will use pan-neuronal/glial, catecholaminergic, and GABAergic Slc30a10 knockouts to selectively
increase Mn in all, catecholaminergic, or GABAergic neurons. This study will test the hypothesis that
catecholaminergic, but not GABAergic, Slc30a10 knockouts mimic the phenotype observed in panneuronal/glial knockouts. Proposed experiments will assay for Mn-induced changes in motor function,
neurodegeneration, neurotransmission, and gene expression under normal conditions and during an
oral Mn exposure relevant to human disease. The proposed study uses a multidisciplinary approach to
further elucidate how brain Mn homeostasis is regulated and how excess brain Mn impacts the
catecholaminergic and GABAergic systems. Proposed studies will be performed under the supervision
of sponsor, Dr. Somshuvra Mukhopadhyay and co-sponsor, Dr. Robert Messing at the University of
Texas at Austin (UT Austin). Dr. Mukhopadhyay is an expert in Mn toxicology, and Dr. Messing has a
well-established career in neuroscience. Their combined expertise and the collaborative environment at
UT Austin are critical for the successful completion of the proposed study and for providing the training
and mentorship necessary for the applicant’s goals of a career in academia and neuroscience
research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Overexposure to the essential metal manganese (Mn) results in basal ganglia neurotoxicity and the development of incurable motor deficits. Proposed experiments aim to determine whether Mn-induced dysfunction of GABAergic or catecholaminergic neurons in the basal ganglia is associated with motor deficits. Proposed experiments also aim to further elucidate the role of the primary Mn efflux transporter SLC30A10 in regulating brain Mn homeostasis.